Contributions of prion strains and substrains to prion zoonotic potential and evolution

Prions are infectious protein-only zoonotic agents that can rapidly evolve in a new replication environment.
Prion strains are encoded by strain-specific conformations of PrPSc, the infectious form of the host-encoded
prion protein, PrPC. Collinge and Clarke hypothesized that prion strains are a mixture of a dominant prion strain
and substrains. In support of this hypothesis, we and others have shown: i) treatment of prions with anti-prion
drugs can result in the emergence of a drug resistant strain, ii) physical methods (e.g. thermostability) that
partially inactivate prions can select for prions with altered strain properties, and iii) strains within a given host
species can have different host ranges. Despite these data, direct evidence for the existence of preexisting
substrains is lacking and, consequently, the contributions of substrains to prion evolution has not been
explored. The long-term goal of this work is to prevent prion evolution to a new replicative environment. The
overall objective of this application is to determine the relative contributions of the dominant prion strain and
substrains to interspecies transmission of prions. In this application we will test the hypothesis is that prion
substrains drive prion transmission to a new PrP genotype. The hypothesis is based on our new discovery that
selective reduction of PrPSc from the biologically cloned hamster-adapted drowsy (DY) strain of transmissible
mink encephalopathy (TME), using two mechanistically different methods, allows for the emergence and
isolation of a preexisting substrain that is distinct from DY. Moreover, this substrain unexpectedly has a
different host range than DY TME. To test our hypothesis, we will first explore the frequency and diversity of
preexisting substrains from stable and unstable prion strains using complimentary methods (conformational
stability, protease digestion, thermostability) to selectively depopulate the dominant strain. The frequency and
diversity of substrains isolated will be determined using complementary in vitro prion detection methods and
animal bioassay. Second, we will explore the well-studied hamster/mouse species barrier using
complementary in vitro and in vivo methods to determine the relative contributions of the dominant strain and
substrains to interspecies transmission. The concept of strain interference between the dominant strain and
substrains will be tested in regards interspecies transmission. These studies are significant since it is critical to
understand the contributions of substrains to prion evolution as current prion treatment methods in
development (vaccination, anti-prion drugs, environmental mitigation procedures) target the dominant strain. It
is therefore possible that these methods will inadvertently result in the emergence of preexisting prion strains
with altered zoonotic potential and/or increased pathogenicity. Overall, these studies will directly test the
Collinge and Clark model of prion strain dynamics and will allow for a more precise evaluation potential of prion
strains to adapt to a new replication environment (e.g., chronic wasting disease transmission to humans).

Public health relevance
Prions are infectious protein-only zoonotic agents that can rapidly evolve in a new replication environment. Little is known about how prions can overcome new replication environments that can include anti-prion drugs, environmental degradation, and transmission to a new host species. The long term goal of this application is to determine the relative contributions of the dominant prion strain and substrains to prion replication in new environments.